MOLECULAR ASPECTS OF LEUKOCYTE ANTIMICROBIAL PEPTIDES

The goal of this project is to elucidate key features of the expression and function of a new family of[unreadable] macrocyclic defensins termed theta -defensins expressed in primate myeloid cells. Rhesus theta[unreadable] defensin 1 (RTD-1) is prototype of this peptide family. The three specific aims are: 1) to characterize[unreadable] the constitutive and inducible expression of theta -defensin mRNAs and peptides in myeloid cells; 2) to test[unreadable] the hypotheses that theta -defensins are delivered to the phagosome during cellular activation and to[unreadable] determine the contribution of these peptides to killing within the phagolysosome; 3) to determine the[unreadable] molecular mechanism of theta -defensin-mediated bacterial killing. These studies should provide insights[unreadable] into the peptides. mechanism(s) of action, molecular basis of selectivity, and other potential interactions[unreadable] with host tissues or microbial structures.[unreadable]